Synergy of Host Defense Mechanisms in the Lung

The fungus Cryptococcus neoformans is a respiratory pathogen that is a relatively frequent
cause of life-threatening disease in individuals with impaired immunity. Macrophages are
critical cells in the control and dissemination of infection in the lung. C. neoformans is a
facultative intracellular pathogen that can replicate in macrophage after damaging the
phagolysosomal membrane. Fungal damage to the phagolysosomal membrane determines the
outcome of the fungal-macrophage interaction. For C. neoformans, as well as other soil
pathogenic fungi, the capacity for virulence has been proposed to emerge from interactions with
phagocytic predators in the environment that select for traits that can then promote virulence in
mammals. In fact, one of the remarkable aspects of C. neoformans pathogenesis is that it is
virulent in many different animal hosts and can replicate in phagocytic cells from mammals,
fish, insects and protozoa. This poses the fascinating question of how a soil organism with no
need for an animal host is able to subvert immune effector cells from so many species. We
hypothesize that this capacity for non-specific virulence comes from its ability to undermine
host cells with an ‘intracellular pathogenesis kit’ that includes the intracellular secretion of
numerous effector molecules. We have preliminary data that C. neoformans releases many
proteins inside murine macrophages that include several well-known virulence factors. In this
application we propose to identify proteins made inside human macrophages and amoeba that
undermine host cells. A subset of these proteins will then be studied in detail to dissect
mechanisms of intracellular pathogenesis. Three specific aims are proposed: Aim 1. To identify
CN proteins produced intracellularly in human macrophages; Aim 2. To identify key CN
compounds produced during its interaction with amoeba; Aim 3. To ascertain the mechanism of
action of certain CN proteins in the intracellular pathogenic strategy in phagocytic human and
protozoan cells. This work will illuminate the mechanisms of C. neoformans intracellular
pathogenesis and this information can be relevant to designing improved therapies, antifungal
therapies and vaccines.

Public health relevance
Cryptococcus neoformans is a major human pathogenic fungus that is acquired by in inhalation into lungs. In the lung the primary host defense system are macrophages that engulf the fungal particles. This application seeks to understand in detail the C. neoformans-macrophage interaction with the ultimate goal of using that information to prevent disease and improve the treatment of cryptococcal disease.